DIETARY PHOSPHATE RESTRICTION--BLOOD PRESSURE, RENAL BLOOD FLOW, GFR

The purpose of this study is to test the hypothesis that dietary restriction of phosphate results in reduction of blood pressure, cardiac output, renal blood flow and glomerular filtration rate.